Psychosocial and Neighborhood Mechanisms and Consequences of Black-White Sleep Disparities on Cognition

Project Summary Black-White differences have been observed in cognitive performance and risk for cognitive impairment, particularly Alzheimer’s disease and related dementias (ADRD). Few studies have examined how sleep may further explain these disparities, especially considering that sleep disturbances are common in Blacks. Since disparities in cognition and sleep have been observed in middle-aged adults, this portion of the lifespan is ideal to investigate the association between sleep and cognitive decline as well as the underlying psychosocial, contextual, and biomarker factors that influence sleep and/or cognitive Black-White disparities. Every year for 4 years, the proposed study will collect measures of sleep duration and quality, cognitive functioning, inflammatory biomarkers (e.g., CRP, IL-6), life stressors, and resilience factors (e.g., spirituality, coping) in a sample of middle- aged Black and White participants from the Healthy Aging in Neighborhoods of Diversity Across the Life Span (HANDLS) study. The overall objective of this study is to identify mechanisms of Black-White sleep disparities and the mechanisms that account for Black- White differences in ADRD risk. The central hypothesis is that racial disparities in sleep will be associated with racial disparities in cognitive decline. Guided by the investigators’ previous research, three specific aims will be tested: 1) To determine if there are racial differences in the daily coupling of sleep and mobile cognitive performance and whether differences in this coupling are moderated by life stressors (e.g., financial strain and neighborhood disorder); 2) To test longitudinal associations among sleep and performance on mobile cognitive assessments and explore the role of life stressors, protective factors (e.g., spirituality and neighborhood cohesion) and inflammation; 3) To determine whether changes in the strength of the daily coupling of sleep and performance on mobile cognitive assessments relate to racial differences in traditional clinical measures of cognitive decline over 4 years, and to elucidate the potential mediational role of inflammation. This approach is innovative because it will not only examine the association between sleep and cognitive functioning over time, but will also examine the relationship of life stressors, sleep, inflammatory biomarkers, and/or resilient factors on racial disparities in cognitive decline. The proposed research is significant because of its potential to identify psychosocial and contextual factors related to impaired sleep and cognition that could serve as the basis for evidence-based behavioral or policy interventions.

Public health relevance
Project Narrative The proposed research is relevant to public health because of the project’s potential to identify adverse and protective factors that modify Black-White disparities in sleep and to elucidate whether Black-White sleep disparities relates to Black-White differences in risk for cognitive impairment, particularly Alzheimer’s disease. Thus, the proposed research is relevant to the NIH’s mission to reduce and/or eliminate health differences that are commonly observed between Blacks and Whites.